Effectiveness and Mechanisms of Multilevel Implementation Strategies to Improve Cancer Prevention Behaviors: A Cluster Randomized Trial

Cancer is a critical national health issue with over 2 million new cancer diagnoses annually within the U.S. and
over 600,000 cancer-related deaths. Preventive actions from childhood and adolescence holds great promise
in preventing cervical, anal, penile, vaginal, vulvar, and oropharyngeal cancer later in adult life. Yet, little is
known about how to leverage this and other facilitators of cancer prevention behaviors in adolescents.
Additionally, studies have also revealed multilevel, multifactorial barriers to improving cancer prevention
recommendations and critical limitations of health system support. Despite this knowledge, many prior cancer
prevention studies in adolescents focus on single-level, single component interventions, leaving many barriers
unaddressed. Of studies that are multilevel and/or multi-component, interventions are often pre-selected to
address “typical” barriers but are not responsive to unique local barriers and local context. To address this
critical gap, we propose a 3-arm cluster randomized controlled trial (RCT) to compare implementation
strategies that are multilevel and multicomponent and guided by in-depth understanding of how multilevel
factors in the practice settings modify the impact of key facilitators. We will use mixed methods (surveys,
interviews, electronic health records) throughout; initially we will evaluate baseline associations between
patient-, provider-, and clinic-level factors and variations in cancer prevention behaviors in children and
adolescents (Aim 1). In Aim 2, we will compare the effectiveness of: 1) A novel “local-tailored” implementation
strategy, co-designed with local care teams to address local barriers and contexts; versus 2) A “prescribed”
strategy, typical of most health systems, that involves pre-specified interventions addressing pre-selected
cancer prevention barriers; versus 3) Usual care. We will evaluate the effectiveness of these strategies on
improving cancer prevention behaviors (primary outcome). Although the need for local tailoring may seem
intuitive, it is unknown if local tailoring will yield superior outcomes that could offset the extra investment
required, supporting the need for this RCT. We will conduct the study within Kaiser Permanente Southern
California, one of the largest community-based care organizations in the U.S. Our study will be guided by the
Consolidated Framework for Implementation Research and the Multilevel Factors Across the Cancer Care
Continuum framework. Completion of these Aims will generate important insights into the multilevel factors
associated with cancer prevention in children and adolescents. This study has high potential to generate
critical guidance for diverse health care settings to improve cancer prevention behaviors, ultimately leading to
fewer diagnoses of new cancers across the U.S.

Public health relevance
Preventive actions from childhood and adolescence holds great promise in preventing cervical, anal, penile, vaginal, vulvar, and oropharyngeal cancer later in adult life. We propose an innovative 3-arm cluster randomized controlled trial to compare the effectiveness of a local-tailored strategy that allows local tailoring of multilevel, multi-component interventions based on local barriers and context, versus a prescribed strategy that prespecifies the multilevel, multi-component interventions that are fixed across sites, versus usual care. This study will be conducted in one of the largest community-based pediatric care organizations in the US and has high potential to provide much needed guidance on strategies for optimizing cancer prevention from early in life.